OCULAR HYPERTENSION TREATMENT STUDY (OHTS)

DESCRIPTION (Investigator's Abstract) "This is an application to become a participating Clinical Center in the Ocular Hypertension Treatment Study (OHTS). The complete details of the OHTS rationale, design and methods are contained in the OHTS Manual of Procedures. This proposal provides complete documentation of the ability of Baylor College of Medicine to screen large numbers of ocular hypertensive patients and to enroll at least 50 eligible patients over a 24-month period. Documentation is provided of the capabilities of the proposed investigators and their staff for the performance of the study in accord with the details of the OHTS Manual of Procedures, the nature and extent of their commitment to Baylor College of Medicine, and a list of practitioners in the area who will refer or follow patients screened for enrollment and randomization to treatment in the OHTS clinical trial."